Multi-Omics Characterization of Plasmodium Vivax Hypnozoites

Abstract
Plasmodium vivax parasites threaten half of the world’s population and are surprisingly resilient to on-going
malaria elimination efforts, partially due to their ability to remain dormant in the liver as hypnozoites for weeks or
months. Here, we propose to conduct state-of-the-art transcriptomic, epigenomic and lipidomic analyses using
materials collected from non-human primates infected with P. vivax, and in vitro infections of human hepatocytes
with patient-derived P. vivax sporozoites. Our analyses will provide a comprehensive perspective on the
molecular and cellular mechanisms underlying the onset, maintenance and exit of P. vivax dormancy, and well
as on the response of the host, from the infected hepatocytes to the organ- and organism-wide responses. Our
findings will not only provide a better understanding of the fundamental processes underlying the fate and
development of liver-stage P. vivax parasites but will also provide a solid foundation to develop better malaria
vaccines and therapies against this important but understudied human pathogen.

Public health relevance
Narrative Plasmodium vivax parasites have the unique ability to remain dormant in the liver before reactivating weeks or months later to cause relapse infections. This feature, that greatly complicates vivax malaria elimination efforts, remains poorly understood due to the difficulties of studying P. vivax liver-stage parasites. We propose to use a combination of novel ‘omic approaches, including the characterization of host cells and parasites spatially and at the single cell level, to study dormancy in vivo in a non-human primate model, and well as in vitro. Our studies will generate novel biological insights on the regulation of liver-stage dormancy and provide immediately-relevant clinical information to better control this important human pathogen.